CARDIOVASCULAR HEALTH STUDY (CHS) - TASK AREA C, STUDY CLOSEOUT

Task area C will be funded as one non-severable task order, be issued on or about May
22, 2023. Preparation and submission of an application and provision of additional
information as necessary for transfer of biological specimens to the NHLBI Biorepository
will commence at the beginning of the task area period. All other closeout activities will
commence on or about May 1, 2024 for an overlapping six month period.